Financially incentivizing HIV prevention among high-incidence populations in LA County: Preparing for implementation

Project Summary/Abstract
New approaches are needed to meet Los Angeles County EHE goals: uptake of PrEP, and knowledge of HIV
status, is lagging particularly among young Black and Latinx Angelenos. Conditional cash transfers (CCTs)—
which encourage behavior change through financial incentives—show promise for HIV prevention behaviors, but
are under-investigated. CCTs should be responsive to local circumstances, and should use behavioral economic
principles to leverage underlying preferences of the target population in order to maximize impact.
This project aims to collect pre-implementation data in order to design an HIV prevention CCT intervention and
implementation strategy for young Black and Latino cisgender men who have sex with men in Los Angeles
County. This includes (A) collecting qualitative data about acceptability, appropriateness, and feasibility of this
proposed CCT from consumers and key stakeholders (policymakers, service providers, community members,
etc.); and (B) conducting a discrete choice experiment to identify the most-preferred attributes of such a CCT.
Discrete choice experiments ask respondents to choose between hypothetical interventions that differ on key
attributes: for example, the amount and frequency of financial incentive payment.
Through a partnership between UCLA, APLA Health & Wellness, and DHSP—and with active engagement of
community members throughout all phases of the research—this study would generate important insights
essential for the design of a successful CCT program. Situated in the “Exploration” stage of the EPIS
implementation framework, it will gather data to inform the subsequent design of a pilot CCT program which can
be implemented and evaluated in follow-on research.

Public health relevance
Project Narrative Conditional cash transfers (CCTs) are a promising intervention for reducing new HIV infections in Los Angeles County by incentivizing maintenance of HIV-negative serostatus or by incentivizing PrEP use—but we lack locally-relevant information to guide successful implementation of a CCT. This community-engaged study will use mixed methods to inform the design of a CCT to promote HIV prevention behaviors among young Black and Latino cisgender men who have sex with men in South Los Angeles. It will also measure pre-implementation factors (acceptability, appropriateness, feasibility) of such a CCT intervention, among the target population and among key stakeholders like policymakers, HIV care providers and organizations, and community members.